Administrative Supplement to Support Preclinical Studies for Rogaratinib (NSC #804782) Clinical Trials

Project Summary/Abstract Not applicable.

Public health relevance
Project Narrative Not applicable.